Investigating the role of signaling feedback in directed cell migration

Project Summary
Cell migration is critical for animal development, homeostasis, and is altered in many diseases. During migration,
a cell’s ability to change direction is essential for processes such as wound healing, immune surveillance, and
tissue morphogenesis. The polarization of cells and the key feedback loops maintaining this polarization allow
for faithful execution of cell migration, however, little is known about how cells remain able to integrate new
information to change its direction. The experiments outlined in this proposal are designed to dissect the
mechanisms by which cells regulate key signaling pathways to control navigation. I will focus on PI3K, Ras, and
Rac signaling, which are active at the front of migrating cells, and membrane-proximal F-actin (MPA) – which is
localized to the rear. Many of these components have been shown to maintain their polarized activity through
positive feedback but it is unclear how exactly negative feedback and crosstalk of these signaling pathways
promote directional change. A better understanding of signaling feedback for these pathways will not only
increase our understanding of how cells maintain faithful cell migration but are likely to shed light on several
other biological processes such as cell division, polarity, and trafficking where these pathways also play critical
roles.
In Aim 1, the canonical signaling pathways involved in cell migration signaling at the leading edge, such as
phosphatidylinositol-3 kinase (PI3K) and Ras signaling will be reinforced to determine the role of signaling
feedback in migration speed, turning, and chemotaxis. Negative feedback signaling onto these pathways has
been proposed as a mechanism to promote cell responsiveness to stimuli change-of-direction, but the
consequences of preventing such negative signaling feedback remain unknown. This will be tested using
unbiased front-localizing PIP3-binding domain to recruit protein fragments designed to augment endogenous
cell signaling. I will also use fluorescence live-cell biosensors to determine if reinforcement of PI3K and Ras alter
the ability of other signaling pathways to regulate cell turning. In Aim 2, I will determine how membrane-proximal
F-actin (MPA) regulates cell migration speed, turning, and chemotaxis. Our laboratory has recently shown that
areas high in MPA are restrictive to protrusion generation but the mechanism by which this occurs is still unclear.
The experiments in this aim will determine how MPA recruitment to the front of the cell alters migration speed,
as well as key signaling pathways, such as RhoA and Rac1, that regulate turning and chemotaxis. I will combine
the use of high throughput quantitative microscopy, fluorescent biosensors, micropatterned migration substrates,
3D matrices, and cell tracking analysis to address these aims.

Public health relevance
Project Narrative Cell migration is ubiquitously important for development, homeostasis, and is altered in many diseases. Directed cell migration requires maintained polarization of key signaling pathways and cytoskeletal organization, however, the mechanisms by which cells maintain the flexibility to change direction is still not well understood. Completion of this proposal will determine how key signaling pathways and membrane-proximal F-actin regulation control cell speed and turning, while determining how signaling from these and other pathways are integrated to control faithful cell migration.